Addressing Underperformance in Clinical Trial Enrollments: Development of a Clinical Trial Toolkit and Expansion of the Clinical Research Footprint

Project Summary
Both the impacts from COVID-19 as well as the increasing complexities of clinical trials, with a particular
emphasis on precision medicine trials, have led to a recent decline in enrollments. This proposal identifies
strategies to address the challenges of enhancing clinical trial enrollments in the hematologic malignancies (HM)
program at the Sidney Kimmel Comprehensive Cancer Center (SKCCC). The two-pronged approach tackles
system barriers and patient barriers. A clinical trial toolkit will be developed to address systems barriers with the
goal of minimizing inefficiencies within our research operations program, increasing enrollment, and ultimately
creating a clinical trial portfolio that best serves our patients. Components of the toolkit include metrics to ensure
feasibility of trials, establish a prioritization queue for resourcing potential studies, trackers for effort and finances,
and performance standards. With many patients preferring to receive their care closer to home, while also having
access to the same novel approaches offered at academic medical centers, the proposal seeks to extend our
clinical research studies to satellite sites. To achieve that end, Dr. Wagner-Johnston addresses strategies to
create the necessary research culture to enhance enrollment. Focus will be placed on establishing leadership
and providing a collaborative learning culture at the satellite sites. Rational portfolio building at the satellite sites
will rely on the same metrics developed as part of the toolkit. Engagement from both physicians and prospective
trial participants is essential and this proposal outlines practical approaches to attend to these concerns.
Involvement in routine research meetings and recognition of physicians' effort in consenting to trials will
incentivize trial participation. Outreach efforts including monthly email newsletters to referring physicians,
updates to our HM website, as well as a better tool to identify potential trials for patients are planned. We will
extend the ongoing work of community health educators affiliated with projects initiated by the Diversity and
Inclusion in Clinical Research Program at SKCCC to include our patients with HM. The outlined research strategy
seeks to improve the operational aspects beginning with pre-trial activation through study closure. Attention to
increased efficiencies will be essential in bringing needed research to satellite sites. Best practices identified
from this project will be readily transferrable to the entire cancer center enterprise at SKCCC and shared with
other academic medical centers. As a nationally recognized lymphoma expert with a strong commitment to the
NCTN and extensive knowledge in clinical research operations, Dr. Wagner-Johnston is poised to lead these
efforts and successfully enhance accruals.

Public health relevance
Project Narrative This research proposal addresses system- and patient-level barriers in accruing to oncology therapeutic trials. The major goals of this project are to develop a clinical trial toolkit to minimize inefficiencies and streamline operations, and to focus on how best to scale research across other sites within our health system, with particular regard to engaging the research team and prospective patients. Protected effort for the duration of the award will provide Dr. Wagner-Johnston the necessary time to develop and implement the metrics, spend time at the satellite sites, and meet regularly with all of the stakeholders involved in these endeavors.